SUCCEED Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core will provide scientific and programmatic leadership to ensure the unifying scientific
mission of the Virginia State University (VSU)-Virginia Commonwealth University (VCU) Massey Cancer Center
(MCC) PartnErship for CancEr Disparities Research and Training (SUCCEED) program and create an
environment in which the scientific and educational projects can flourish without the pressures of routine
administrative tasks and interruption. This core will be the hub of SUCCEED. It will support the 2 research
projects, implement a system for reviewing proposed new pilots during the project funding period, support the
Cancer Research Education Program (CREP) activities, and will be responsible for regulatory oversight, fiscal
management, facilitating communication among the investigative teams, and strategic planning. It will also
provide a unifying entity for internal and external communication for strategic planning and dissemination. The
Administrative Core will be led by a team of multi-principal investigators (MPIs), along with the guidance of an
Internal Advisory Committee. The MPI team includes Robert A. Winn, MD (VCU MCC Contact MPI), Vanessa
Sheppard, PhD (VCU MCC), Omar Faison, PhD (VSU Contact MPI), and Daniel Roberts, EdD (VSU).The aims
of the core are to: Aim 1: Provide overall support via close interaction with VSU and MCC leadership, the Internal
Advisory Committee, and the NCI; Aim 2: Provide administrative, budgetary, and regulatory oversight for
SUCCEED; and Aim 3: Organize, coordinate, and monitor progress toward overall SUCCEED goals.